Approach Bias Retraining for Nicotine Addiction among Dual Combustible and Electronic Cigarette Users

ABSTRACT
Electronic cigarette (ECIG) use has become a popular method for nicotine delivery. Combustible cigarette (CC)
cessation or reduction are the primary reasons for ECIG uptake among adults.1-3 Yet, most CC smokers who initiate
ECIG use do not fully transition from CC to ECIG, despite intending to quit CC completely.4-9 Longitudinal work has
found that 89% of dual users—users of ECIG and CC concurrently--remain dual users a year after initial
assessment.10 Continued dual use is alarming because it is associated with increased nicotine use and
dependence.11 Consequently, dual users are exposed to CC toxins and constituents, including carcinogens, at
levels comparable to exclusive CC smokers.12 Theory and empirical findings suggest that targeting automated,
impulsive, implicit processes may hold promise for substance use reduction and cessation.13-18 Specifically,
retraining approach bias, or the approach action tendency toward stimuli related to the substance of interest, has
been effective in alcohol use disorders (i.e., reduction in relapse rates by 10%-13%).18-20 When applied to CC-
related stimuli, approach bias retraining has been found to reduce approach bias, which is subsequently related to
greater number of days abstinent from CC following a self-guided quit attempt.21
This R21 application will evaluate the initial efficacy of approach bias retraining among dual CC/ECIG users. To
obtain initial effect size data for a larger R01 follow-up study, we will randomly assign 90 dual CC/ECIG using adults
to one of three conditions: (1) CC+ECIG retraining; (2) CC only retraining; and (3) sham training (control).
Participants will complete 4 sessions of approach bias retraining using the respective stimuli and then engage in a
self-guided quit attempt to abstain from all nicotine products. Each session will consist of 15 minutes of
computerized approach bias retraining and a brief assessment. Participants will provide baseline data, ecological
momentary assessment (EMA) data during the first two weeks post-intervention, and complete follow-ups at 4- and
6-week post-intervention. Abstinence will be assessed during the intervention (weeks 0-4), during the EMA period,
and at both follow-ups.
The proposed study represents a crucial and important ‘next step’ in translating basic research to strategies for
treating nicotine dependence among dual CC/ECIG users. The investigation addresses an important public health
issue by testing a brief computerized intervention - informed by basic research - that may lead to a more effective
treatment for at-risk nicotine users while simultaneously isolating explanatory mechanisms. The expected findings
should: (1) guide advances in the theoretical conceptualization of nicotine addiction for dual users and mechanisms
involved in maintaining and abstaining from CC and ECIG; and (2) provide initial effect size data for a brief
intervention, and thus provide the necessary data for a large-scale follow-up trial.

Public health relevance
PUBLIC HEALTH NARRATIVE Current combustible cigarette (CC) smokers are more likely than other groups to use electronic cigarettes (ECIG) and engage in prolonged use of both products, with 40.8% of ECIG using adults reporting dual ECIG and CC use. This co-use is concerning from a public health perspective because (1) dual CC/ECIG users are apt to experience cancers and tobacco-related health risks at rates comparable to exclusive CC users and (2) dual CC/ECIG use may prolong and sustain nicotine addiction, and consequently, inhibit CC cessation among those who might otherwise quit; yet, little is understood about clinical pathways to support CC and ECIG cessation among dual users. The goal of the current R21 proposal is to evaluate CC and ECIG quit patterns following a theoretically and empirically supported brief computerized intervention that targets approach bias toward drug-related stimuli (i.e., CC and ECIG stimuli) among dual users.